Addressing Key Social Contributors to Disparities in MatErNal MorbiDity in Southeastern Wisconsin - ASCEND WI Center

There are significant disparities in severe maternal morbidity and mortality in the US. Social determinants of health and social risk factors have a central role in maternal health disparities. Our team provides healthcare services in Milwaukee, Wisconsin, one of the five most segregated cities in the US. The adverse health effects associated with residential segregation, concentrated poverty, and neighborhood conditions result in perpetuated racial disparities in all health outcomes in Southeastern WI, including maternal health outcomes. In this proposal, we aim to address key social/non-medical risk factors for racial disparities in maternal morbidity in Southeastern Wisconsin identified by our research community and community partners. These risk factors include housing instability, medical mistrust, and fragmented access to preventative care postpartum. We plan to address these risk factors with two research projects involving community stakeholders in housing (research project 1), and community-based doulas (research project 2). The two projects were conceptualized and developed in collaboration with community partners with synergy of improving maternal health throughout the continuum of preconception, pregnancy, and postpartum. The MCW Center’s theme is Addressing Key Social Contributors to Disparities in MatErNal MorbiDity in Southeastern Wisconsin - ASCEND WI. ASCEND WI has four overarching aims: 1) Partner with community organizations to mitigate the impact of social risk factors on maternal health, 2) Develop and evaluate interventions to address social/non-medical risk factors for racial disparities in maternal health, 3) Disseminate findings to relevant stakeholders and policymakers, and 4) Train a diverse group of early-stage scientists in maternal health research. The ASCEND WI team utilizes innovative approaches and skilled academic and community-based partners to create sustainable change and will work effectively to eradicate maternal health disparities in Southeastern Wisconsin and beyond.

Public health relevance
In this proposal, we aim to address key social risk factors for racial disparities in maternal morbidity in Southeastern Wisconsin identified by our research community and community partners. These risk factors include housing instability, medical mistrust, and fragmented access to preventative care postpartum.